VCID Biomarkers Coordinating Center

Project Summary/Abstract
The MarkVCID initiative is responsible for executing one of NIND’s highest identified priorities for reducing the
contribution of cerebral small vessel disease (SVD) to cognitive impairment and dementia: selection and
validation of SVD biomarkers for use in VCID research and trials. MarkVCID2, the current phase of the
consortium, is structured as a single coordinating center (CC) based at Massachusetts General Hospital
(MGH) and nine performance sites comprised of 15 US medical centers. To accomplish MarkVCID2’s goal of
clinically validating selected SVD biomarkers for full readiness for trial application, each award site will be
required to enroll at least 200 individuals meeting MarkVCID2 eligibility criteria over two years and retain them
for annual follow-up visits over three years. The enrolled population will be required at a minimum to include
adequate numbers of African American, Hispanic, and Caucasian individuals to ensure generalizability of the
findings to typically underrepresented populations as well as adequate numbers of subjects across the spans
of age and cognitive impairment potentially suitable for SVD trials.
The COVID19 pandemic has posed considerable barriers to meeting these ambitious goals, particularly for
recruitment in the typically underrepresented populations where obstacles to research participation and staffing
shortages have the greatest negative impact. The current proposal seeks to overcome these challenges by
equipping the MGH CC to serve as a central core of resources for site recruitment and retention of the targeted
diverse subject groups. We propose to establish two key new positions at the CC: a Recruitment and Retention
Project Manager and a Data and Reporting Specialist. The Project Manager will serve as the central
coordinator of recruitment and retention strategies with focus on underrepresented populations: identifying,
disseminating, and customizing best practices, recruitment materials, and lessons learned from targeted
community outreach initiatives. The Data and Reporting Specialist will develop and deploy processes at the
CC for real-time monitoring and communication to sites of actionable recruitment and retention data that can
be used to guide strategy, allocate effort, and avoid the burden of developing their own tracking tools.
By centralizing the demanding and time-consuming processes of identifying successful recruitment and
retention strategies and real-time tracking of recruitment/retention diversity, these two positions will take
substantial burden off site personnel and work against the increasingly prevalent negative feedback loop of
stressful work environments causing loss of site personnel. These will be sustainable positions built on the
expertise accumulated by the MGH CC. By substantially reducing duplicative work, the added positions will
allow sites to redirect their staff to on-the-ground recruitment and study visit procedures. We anticipate that the
resultant improvement in site working conditions will improve career satisfaction and retention of experienced
site staff and ultimately MarkVCID2’s recruitment and retention performance.

Public health relevance
Project Narrative/Relevance The Massachusetts General Hospital Coordinating Center leads a team of 15 US medical centers (collectively known as MarkVCID) in a collaborative effort to identify markers of diseases of the brain's small blood vessels that substantially contribute to age-related cognitive impairment and dementia. The current proposal, in response to NOSI NOT-NS-23-001, is for the Coordinating Center to directly address the consortium-wide staffing challenges that have resulted from the COVID19 pandemic, which have significantly slowed MarkVCID’s recruitment and retention efforts for at least 1800 diverse subjects. The proposed Recruitment and Retention Project Manager and Data and Reporting Specialist will centralize tasks at the Coordinating Center that currently sidetrack research sites’ effort, allowing the sites to effectively recruit and retain research participants particularly from groups often underrepresented in research studies.